Stanford Medicine Center for Longevity and Healthy Aging Research Education Core

REVISED PROJECT SUMMARY—RESEARCH EDUCATION CORE
The goal of the Stanford Medicine Center for Longevity and Healthy Aging is to enhance the research
workforce by training promising scientists for sustained careers in research on longevity and aging. Our
REC will provide training, mentoring, and support our pilot awardees in conducting translational research
on aging that integrates biological, social, behavioral, and cultural considerations using various
innovative techniques (e.g., biomedical data science, digital health, precision medicine, virtual
reality/simulation-based interventions, qualitative research, mixed-methods research, and
implementation science). We will fund three 12-month mentored pilot awards per year, designed and
implemented with the guidance of committed and skilled research mentors. Each pilot awardee will
choose a primary mentor (from their home organization) and a secondary mentor from any of our
member organizations. We will provide ongoing mentoring and support to the pilot awardees after the
funding period, including technical assistance in research grant writing toward independent NIH funding
so that they gain much of the knowledge, attitudes, and skills necessary to transition into viable research
careers, including conduct of transdisciplinary aging research, authoring manuscripts, competing for
external funding, developing mentoring and team building strategies, and how to design and implement
their career development plans. Our RCMAR Scientists will learn in an environment that emphasizes
teamwork and teaches that the most innovative research is a product of team science that bridges all
disciplinary areas spanning the aging research landscape. Our specific aims are:
1: Provide pilot awards to early career researchers (RCMAR Scientists) from the Stanford Medicine Center
for Longevity and Healthy Aging Consortium to conduct transdisciplinary collaborative, biobehavioral and
socio- cultural longevity and healthy aging research.
2: Mentor and support junior investigators in conducting clinical and translational research with aging
populations.
3.Provide robust research training (in longevity and healthy aging), professional, and leadership
development opportunities to junior investigators both during and after the pilot funding.
Specific Aim 4: Build the Stanford Medicine Center for Longevity and Healthy Aging into a research
leadership pipeline by mentoring junior scientists to assume leadership roles in the future.